Fungal regulatory systems directing mammalian host colonization

ABSTRACT
The fungus Candida albicans is a ubiquitous member of the human gut microbiota, yet also
causes mucosal disease and life-threatening disseminated infections. The research program
that I describe here seeks to understand the links between the fungus' facet as intestinal
commensal and its ability to proliferate in disparate organs. The program is built upon recent
findings from my laboratory which ¾ through systematic genetic screens conducted in mouse
models of gut colonization, oropharyngeal candidiasis and disseminated infections ¾ reveal
that fungal genetic determinants of fitness in the gut also shape the interactions of the fungus
with other tissues. The proposed study encompasses three specific directions: (i) elucidating the
mechanisms of activation and inhibition of a regulator of fungal sphingolipids which is active in
the gut and inside human neutrophils; (ii) defining the effector genes and extracellular cue(s) of
a regulator that promotes binding to intestinal mucus; and (iii) identifying C. albicans gene
products that enable the fungus to inhabit the intestinal mucus layer. The proposed research is
expected to reveal basic principles underlying the interplay between mammalian host and the
most prominent fungus residing in humans.

Public health relevance
Narrative The fungus Candida albicans causes significant morbidity and mortality in the United States, particularly among individuals that have a weakened immune system such as cancer patients undergoing chemotherapy or transplant recipients. Using animal models of Candida colonization and infection, my laboratory has uncovered fungal regulatory genes that are key determinants of the Candida-host interplay. We will study of these regulatory systems, their associated traits and the molecular mechanisms whereby they effect the interactions with mammalian cells.